Parental Well-Being and Child Development

Abstract
An estimated 43 percent of children under age 5 in low- and middle-income countries (LMICs) will not reach
their full developmental potential due to poverty, stunting, or inadequate psychosocial stimulation. Parenting
interventions that promote responsive caregiving can effectively improve early childhood development (ECD)
outcomes in LMICs, at least in the short-term. Yet to date, 93 percent of parenting interventions globally have
exclusively focused on mothers, and longer-term follow-ups show early impacts fade out over time.
Parenting interventions that that solely target mothers overlook the potential gains from engaging fathers, who
can influence children’s outcomes directly, via increases in responsive caregiving and reductions in harsh
discipline, and indirectly, via improvements in maternal and family wellbeing stemming from increased
emotional support and participation in household tasks, and reduced intimate partner violence (IPV). Engaging
couples to achieve whole-family behavioral changes could lead to larger program impacts than engaging only
mothers, given that fathers are often the household head with significant decision making power and influence
on family dynamics in LMICs. Since familial support can play a key role in supporting long-term behavior change,
interventions that engage both parents may also stand the best chance to sustain impacts over time.
Our proposal asks: Does engaging both parents as couples lead to larger and more sustained improvements in
parenting behaviors and ECD outcomes relative to engaging only mothers? We will develop and experimentally
test Msingi Bora Familia (MBF), a responsive parenting and family wellbeing intervention that integrates father-
inclusive, gender-equitable and family-focused curricula into Msingi Bora (MB), a NICHD-funded responsive
parenting intervention by our team. MB significantly improved short-term maternal parenting behaviors and
ECD, but impacts after two years were smaller. We will test MBF in a 3-arm cluster randomized controlled trial
in which 120 villages and 1,200 households with young children from rural Kenya will be randomly assigned to:
(1) a control group; (2) mothers-only; or (3) “couples” (though we allow for myriad family configurations). We
will test the relative effectiveness and cost-effectiveness of treating only mothers versus engaging both parents.
We will collect baseline and follow-up surveys on measures of child cognitive and socioemotional outcomes,
paternal and maternal caregiving behaviors and mental health, experience of IPV, attitudes towards gender roles,
social norms, and quality of the couple’s relationship. A second follow-up survey two years later will test for
sustained impacts on parental and family measures, as well as ECD outcomes. We will collect cost data during
implementation to estimate the relative cost-effectiveness of each intervention model, and explore the mediating
pathways of change to inform the generalizability and sustainability of the different intervention models.
The goal of our study is to produce rigorous evidence on the distinct role of fathers on children’s development,
and to test if their inclusion improves the effectiveness and sustainability of parenting interventions in LMICs.

Public health relevance
Project Narrative Parenting interventions that promote responsive caregiving can help remediate early disadvantages for the 43% of children under five in low- and middle-income countries (LMICs) who experience compromised early childhood development (ECD). However, the vast majority of parenting programs focus exclusively on mothers and their early impacts fade over time. Our study asks how much more effective, cost-effective, and sustainable an ECD parenting program can be that engages both parents to achieve whole-family behavioral changes relative to programs that focus only on mothers? We will develop and test a new intervention focused on whole families in a large-scale cluster randomized effectiveness trial across 120 villages in rural Kenya to determine how involving couples versus only mothers relates to family and child outcomes in both the short- and medium-term.